Quantifying the Breadth and Duration of Immunity Induced by Meningococcal B Vaccines

Project Summary/Abstract
Meningococcal disease caused by the bacterial pathogen Neisseria meningitidis is responsible for significant
morbidity and mortality worldwide. Preventing meningococcal disease is of particular public health importance
because of the sudden onset of symptoms, rapid progression, and high case fatality even among previously
healthy individuals. Serogroup B meningococcal (MenB) disease has caused outbreaks in multiple countries
and the US, where several outbreaks occurred on college campuses in recent years. Teens and young adults
are one of the groups at highest risk of invasive disease. In 2014 and 2015, two novel MenB vaccines, Bexsero
(4CMenB, GSK) and Trumenba (rLP2086, Pfizer) were licensed in the US for 10-25 year olds. The extent to
which these vaccines induce broadly protective, persistent immunity is unknown, limiting our ability to
understand the kinetics of the immune response and to develop optimal vaccination strategies. In
addition, no studies have evaluated these two vaccines using the same measures of immunity against
the same disease-causing MenB isolates. We aim to advance the field of vaccinology and to improve efforts
to prevent deadly cases of MenB disease by evaluating both the short-term and long-term immunogenicity of
these MenB vaccines and by investigating the breadth of immunity induced against the diversity of MenB
strains that cause disease. To achieve these aims, we will conduct clinical epidemiological research using a
novel serum bank that we collected from teens and young adults during two of the first studies of Bexsero
immunogenicity in the US, and we will extend the period of follow up among this unique cohort. In addition, we
will use similar methods to enroll young adults into a prospective longitudinal study to evaluate Trumenba
immunity. To evaluate immune responses, we will conduct serum bactericidal antibody assays using
externally-derived human complement (hSBA) and a recently developed serum bactericidal antibody assay
using intrinsic human complement (iSBA) to investigate how broadly immunogenic both vaccines are against a
collection of dozens of MenB isolates and whether immunity persists long term. We will then develop statistical
models to evaluate hSBA and iSBA responses and the relationship between these markers of functional
immunity over time. We aim to rigorously and simultaneously evaluate Bexsero and Trumenba vaccine-
induced immunity against the same panel of MenB strains. Meningococcal B vaccines are critical tools for the
prevention of invasive meningococcal disease. Our research will combine new epidemiologic data, novel
laboratory methods, and statistical models to generate urgently needed evidence that will increase our
understanding of vaccine-induced immunity. Our results can be used to inform vaccination policy so that
effective, targeted vaccination strategies can be designed and implemented.

Public health relevance
Project Narrative Two novel meningococcal serogroup B vaccines, Bexsero and Trumenba, were recently licensed in the US to protect against invasive meningococcal disease, a significant public health threat given the sudden onset, rapid progression, and high case fatality even among previously health young adults. We will evaluate the kinetics of immune responses induced by these vaccines against a broad panel of disease-causing meningococcal B strains with both the gold-standard correlate of protection, serum bactericidal antibody assays using extrinsic human complement (hSBA), and a new serum bactericidal antibody assay using intrinsic human complement (iSBA). We aim to provide evidence about the breadth and duration of immunity induced by meningococcal B vaccines, to inform the design of optimal vaccination strategies to prevent meningococcal disease, and to advance the fields of vaccinology by increasing our understanding of the protective effects of vaccines.